BD FACSDiscover S8 Spectral and Imaging Cell Sorter

PROJECT SUMMARY
A group of eighteen NIH-funded investigators requests funding for the purchase of a BD FACSDiscoverTM
S8 spectral and imaging cell sorter, for installation in the Cytometry and Cell Sorting Core at Baylor College of
Medicine. These investigators use samples from a variety of species including humans, rats, and mice for their
research in the fields of immunology, cancer biology, cardiovascular disease, cancer immunotherapy, virology,
parasitology, and neuroscience. Besides the users from two different institutions listed in this application, the
instrument will be accessible, through an existing memorandum of understanding, at internal cost to all
investigators at Baylor College of Medicine and the Texas Medical Center. Baylor College of Medicine, Rice
University, the University of Houston, the University of Texas Health Science Center at Houston, the University
of Texas M.D. Anderson Cancer Center, the University of Texas Medical Branch at Galveston, and the Texas
A&M Health Science Center - Institute of Biosciences and Technology.

Public health relevance
PROJECT NARRATIVE The installation of a BD FACSDiscover S8 Spectral and Imaging Cell Sorter in the Cytometry and Cell Sorting Core at Baylor College of Medicine will enhance the capabilities, quality, and throughput of research projects of multiple investigators at Baylor College of Medicine and in surrounding institutes. These investigators focus on immunology, cancerology, , virology, parasitology, and neuroscience.